Sleep Quality and Mechanistic Links to Alzheimer Disease and Related Disorders among older Mexican Americans and Non-Hispanic Whites

PROJECT SUMMARY/ABSTRACT
One of the most exciting recent advances in clinical neuroscience has been the establishment of a connection
between sleep and Alzheimer's Disease and Related Dementias (ADRD). Patients with ADRD frequently
experience poor sleep quality/disorders and growing evidence, including from our team, suggest that poor
sleep quality increase risk of developing ADRD. This bidirectional association has profound implications for
prevention and treatment, however many questions remain. Mexican Americans (MAs) represent the fastest
growing ethnic group in the U.S. and MAs face numerous health disparities including greater
metabolic/vascular risk compared to Non-Hispanic Whites (NHWs). Recent evidence, while controversial,
suggests greater subjective sleep problems in Hispanics, but these data are lacking in older Hispanics,
especially MAs, and little is known about objectively measured sleep. Our cost-efficient and innovative study
will address many of these gaps. The overall objective of this proposal is to determine the association between
sleep quality (objective and subjective measures) and cognitive impairment including ADRD among MAs and
NHWs, and to elucidate targeted pathways linking these conditions. We will leverage the ongoing Health &
Aging Brain among Latino Elders (HABLE) study to cost-efficiently investigate objectively measured sleep
among 500 community-dwelling MAs and 500 NHWs across level of cognitive impairment (approximately 40%
with Mild Cognitive Impairment/ADRD). The HABLE study has deep phenotyping and biomarkers for
metabolic/vascular health. In addition, all participants will have a brain MRI and a subset will have amyloid PET
scans, cost-efficiently enabling our investigation of neurodegenerative and vascular/inflammatory pathways
associated with sleep quality. We propose to conduct these aims as part of the HABLE-Dormir ancillary study:
1) To characterize objective and subjective sleep quality among older NHWs and MAs across the cognitive
spectrum, 2) To examine the longitudinal association between sleep quality and 2 to 3-year cognitive decline,
3) To determine the association between sleep quality and key mechanistic pathways including vascular and
inflammation and 4) To investigate the association between sleep quality and biomarkers of amyloid (PET
scans and plasma Aβ40 and Aβ42) and other measures of neurodegeneration (plasma tau, NFL, and
hippocampal atrophy). We have an unprecedented opportunity, working with a very experienced and
multidisciplinary team, to conduct the first-ever comprehensive investigation of several key pathways among
MAs and NHWs that may link sleep and ADRD. Understanding the longitudinal association and mechanisms
between sleep and ADRD among older MAs will help with the early detection and prevention of ADRD in this
underserved population as well as all older adults.

Public health relevance
PROJECT NARRATIVE Poor sleep quality and sleep disturbances have been linked to an increased risk of cognitive aging and dementia, but evidence in diverse populations is lacking, particularly for Mexican Americans. We propose to investigate the relationship between sleep quality/disorders and Alzheimer's disease and related dementias (ADRD) in older Mexican Americans and Non-Hispanic Whites and to explore the underlying vascular and neurodegenerative pathways underlying this connection. Knowledge gained from this study could enhance the early detection and prevention of ADRD in Mexican Americans and provide critical risk information for all older adults.